Targeting ß-TrCP regulators to improve CRC response to chemotherapy

PROJECT SUMMARY
Improved treatment of colorectal cancer (CRC) requires better understanding of key regulators of survival
and proliferation of intestinal epithelial cells and their crosstalk with immune system. Upregulation and
hyperactivation of the β-TrCP E3 ubiquitin ligase underlie CRC pathogenesis and poor responses to
chemotherapy. While directly inhibiting β-TrCP proved to be practically difficult, here we propose to target the
key regulators of β-TrCP in CRC including proteins that stabilize its mRNA (IGF2BP1) and protein (PARP11).
Our published and preliminary data indicate that IGF2BP1 and PARP11 act within malignant cells as well as
within benign immune cells of the tumor microenvironment (TME) to stimulate colorectal tumors growth and
progression and limit their responses to chemotherapeutic regimens. These data support an overarching
hypothesis that targeting IGF2BP1 and PARP11 should elicit potent anti-tumor effects and improve the efficacy
of anti-cancer chemotherapies. We will test this hypothesis in three independent yet integrated Specific Aims. In
Aim 1 we will determine the roles of IGF2BP1 in cancer cells and in the pro-tumorigenic TME and in responses
to therapy. We will utilize genetic modulation of IGF2BP1 expression in CRC cells and cells of the TME to
understand the role of IGF2BP1 for tumor growth, metastases, and sensitivity to the FOLFOX regimen, which is
a standard of care chemotherapy for CRC patients. Mechanisms governing IGF2BP1 expression in TME as well
as mechanisms of TME-dependent involvement of IGF2BP1 in sensitivity to chemotherapy will be investigated.
Aim 2 will determine the importance of PARP11 in growth and progression of intestinal tumors as well as their
responses to anti-tumor therapy. We will use genetic, molecular, and pharmacologic approaches to modulate
PARP11 in colon adenocarcinoma cells or in the non-malignant TME cells to determine the importance of
PARP11 in pro-tumorigenic phenotypes in vitro and ability to form orthotopic tumors and liver metastases in vivo.
PARP11-dependent mechanisms underlying control of malignant cells by anti-tumor immune system and
responsiveness of tumors to chemotherapy will be investigated. Aim 3 will examine the effects of
pharmacological targeting of the regulators of β-TrCP to improve the responses of colon adenocarcinoma tumors
to chemotherapy. We will determine the anti-tumor effects of novel, potent and highly selective inhibitors of
IGF2BP1 (AVJ16) and PARP11 (ITK7) as mono-agents and their ability to improve the responses to FOLFOX
regimen.
Completion of these studies should gain the insight on the importance of IGF2BP1 and PARP11 in
colorectal tumor growth and metastasis, and characterize these regulators as potential vulnerabilities, which
could be exploited for improving chemotherapy of CRC.

Public health relevance
NARRATIVE Colorectal cancer (CRC) is a lethal disease with limited treatment options. Pilot studies suggest that regulators of levels of the β-TrCP E3 ubiquitin ligase such as IGF2BP1 and PARP11 may contribute to CRC tumor growth, its control by anti-tumor immunity and responses to chemotherapy. Studies proposed here will determine the importance of IGF2BP1 and PARP11 in growth, progression, and metastasis of colorectal tumors and in their responses to therapy; these studies should reveal the IGF2BP1- and PARP11-dependent pathways as vulnerabilities that could be exploited for CRC treatment.